EFFECT OF FLUOXETINE ON STEADY STATE CARVEDILOL STEROSPECIFIC PHARMACOKINETICS

The primary purpose of this study is to assess the effects of cytochrome P450 isoenzyme inhibition by fluoxetine (Prozac) on the stereospecific pharmacokinetics of carvedilol in patients with heart failure.